Socio-environmental determinants of grocery sales and community nutrition in transition in Nunavut, Canada

PROJECT SUMMARY/ABSTRACT
In the Canadian Arctic territory of Nunavut, the Inuit majority consumes a mixed diet composed of traditional,
harvested ("country") food and store-bought foods. Country food is nutrient-rich and remains a substantial
dietary component; store-bought food is typically more energy dense and highly processed while also growing
in its dietary dominance over country food. In recent years, overweight, obesity, and associated chronic
conditions have been on the rise in the territory. This shift is fueled by built (advent and growth of food
retailers) and natural (harvesting hazard-related) environmental dynamics. As harvesting trail safety is
jeopardized by climate change and environmental hazards, country food procurement can become difficult. In
a prior qualitative study, the applicant discovered that, in these leaner times of decreased country food harvest,
community members seek sustenance elsewhere—very often at the grocery stores. The body of evidence
associating such retail food environments to diet-related health outcomes is expanding. Investigating grocery
sales allows for rigorous, cost-effective, and time-efficient monitoring of store-bought contributions to
population diet, nutrition, and health. Using grocery retailer-donated data from 21 stores across Nunavut, this
research will, for the first time in the circumpolar north, explore store-bought components of the local diet. The
aims are to: (1) examine nutritional and dietary pattern trends across Inuit-defined seasons and community
population size quintiles (a proxy for degree of traditional subsistence activity) to better understand the nutrition
transition, and (2) model the unsafety of nearby harvesting trails as a predictor of more total grocery and/or
animal protein purchases. This project is grounded in long-standing partnerships with community and territorial
government entities in the health, food security, nutrition, and public policy arenas in Nunavut, and represents
a multisectoral academic, public, and private (the North West Company food retailer) collaboration in pursuit of
shared analytic objectives. Through the detailed training plan structured around the applicant’s research aims
and career goals, a multidisciplinary sponsorship team will support her development as an independent
academic researcher. The training goals include (1) developing and integrating advanced methodological
techniques in social and environmental epidemiology, (2) enhancing skills in the design, conduct, and
communication of community health studies with policy impacts, and (3) gaining further experience with
sustainable and effective approaches to community-partnered research. Altogether, the training and research
plans will prepare the applicant for a career as a leading socio-environmental and Arctic epidemiological
researcher, instructor, and mentor. By the successful conclusion of this F31, she will have built an unrivaled
7-year database combining environmental, social, and nutritional data for Nunavut. This will pave the way for
continued, impactful work as a postdoctoral researcher pioneering studies at the interface of built and natural
environmental drivers of Arctic community nutrition and health in transition.

Public health relevance
PROJECT NARRATIVE Rapid environmental and social changes in the Arctic are driving the nutrition transition—the population dietary shift away from traditionally harvested foods and toward store-bought foods. This shift is evident in the predominantly Inuit territory of Nunavut, Canada, where harvesting is becoming increasingly expensive and dangerous due to rising environmental and weather-related hazards. Using grocery retailer-donated data from 21 stores in Nunavut, the proposed research seeks to 1) examine whether a) food group contributions to key nutrients, and b) nutrient densities among total sales, differ by Inuit-defined season and/or community size quintile, and 2) model whether a period of harvesting trail unsafety is followed by sales increases in a) animal protein and b) total groceries.